GLUCOSE THRESHOLD FOR CEREBRAL DYSFUNCTION DURING HYPOGLYCEMIA IN IDDDM

Clinical observation suggests that cognitive function can remain impaired after hypoglycemia, despite normalization of plasma glucose. To determine that such a delay occurs, and whether it is influenced by the duration of hypoglycemia, we compared P300 latency (prolongation is a marker of hypoglycemic cognitive dysfunction), after different periods of hypoglycemia. 17 normal volunteers had 2 hypoglycemic clamp studies. Plasma glucose was lowered to 50mg/dl for 60 or 180 min. P300 latency was measured at baseline, during hypoglycemia and during glucose recovery. All subjects showed P300 prolongation during hypoglycemia. No change was seen during 3 euglycemic control studies. We plan to measure the delay in normalization of cognitive function after hypoglycemia in poorly controlled diabetics, we expect this will be more prolonged.